The development of genetically-based pathways underlying problematic alcohol use

PROJECT SUMMARY/ABSTRACT
Problematic alcohol use (ALC) has devastating consequences for individuals, families and society. It is
imperative to illuminate the poorly understood genetic basis of ALC to improve the precision of prevention and
treatment. Research shows that heritable adolescent precursors to ALC are conduct problems (CP), depression
(DEP), and particularly their co-occurrence. Moreover, temperament provides important clues to the diverse
genetic origins of CP and DEP. This suggests that combinations of CP and DEP symptoms and temperament
characteristics may yield novel, genetically-distinct traits that could become new, more precise targets of ALC
prevention. The research targets analysis of four prospective cohorts that will be integrated using advanced data
harmonization: Adult and Family Development Project (PI: Chassin), Michigan Longitudinal Study (PI: Zucker),
Tracking Adolescents’ Individual Lives Survey (PI: Oldehinkel), and Avon Longitudinal Study of Parents and
Children (PI: Timpson). Collectively, these datasets provide multigenerational extended pedigrees densely
affected with ALC, genomic data, longitudinal data spanning 10+ years, and rich phenotyping of key measures
that are similar or identical across cohorts. Aim 1 will examine patterns by which symptoms of CP and DEP and
temperament characteristics are inherited, thus identifying highly heritable traits underlying ALC. Aim 2 will
employ group-based multi-trajectory modeling of these heritable traits across adolescence (ages 11-18) and
relate them to ALC outcomes into adulthood. In Aim 3, sex differences in the multi-trajectory groups and in their
associations with ALC will be examined. The complementary research and training aims will be instrumental in
launching the candidate’s independent research program on the genetics and development of alcohol use
disorder (AUD). The proposed award will provide training in an optimal scientific environment, the University of
Pittsburgh, across several key areas: (1) quantitative genetics, large-scale genotypic analysis, genetics of AUD,
and other advanced methods with Dr. Bernie Devlin, primary mentor and expert in statistical genetics, and Dr.
Arpana Agrawal, consultant and expert in the genetics of AUD; (2) development of AUD and comorbid
psychopathology into adulthood with Dr. Brooke Molina, co-mentor and expert in AUD and comorbidity; and (3)
data harmonization through consultation with Dr. Patrick Curran, an expert in longitudinal data harmonization.
This training will equip the candidate to conduct powerful genetic studies, to take advantage of ever-increasing
open data, and to contextualize genetic influences on AUD. With the support of this award, the candidate will
gain skills to conduct genetically-informative research that will improve the precision of identification for
adolescents at-risk for AUD. This program of research has the potential to advance the field by producing insights
into AUD etiology that could eventually inform precision-medicine based prevention.

Public health relevance
PROJECT NARRATIVE Discovering unique, biologically-based pathways to problematic alcohol use (ALC) will help us tailor interventions for this condition. This proposal will examine patterns by which adolescent risk factors for ALC are inherited in families to identify new genetically-based traits; these traits could lead us to discover novel individualized treatment targets for ALC. Testing sex differences in these new genetically-based traits and their relation to ALC will shed light on whether differing treatments are needed for males and females.